Medical Scientist Training Program

ABSTRACT
The central mission of the Medical Scientist Training Program (MSTP) at Columbia University's Vagelos
College of Physicians and Surgeons (VP&S) is to train clinician-scientists to become leaders in biomedical
research. Growing complexity of medicine and science has made it challenging to sustain a robust pipeline of
clinician-scientists into the biomedical workforce. The VP&S MSTP has implemented efficiencies to integrate
medical and PhD research training that keep pace with the interdisciplinary, quantitative, collaborative, and
diverse nature of biomedical scholarship. The VP&S MSTP has evolved a flexible curricular model, providing
outstanding and efficient training and mentorship to support the output of committed, clinically fluent,
biomedical researchers. Trainees undertake an 18-month preclinical medical curriculum followed by 2 clinical
clerkships, then PhD research for 3.5-4.5 years, and finally the major block of clinical clerkships. Because of
MSTP's emphasis on integration, preclinical students are engaged in PhD courses and lab rotations; and PhD
students are engaged in a unique clinical competence program. After the 7 or 8 year MD-PhD program,
trainees emerge as creative, rigorous, diligent, resilient scientists who are also exceptional and compassionate
clinicians. Specific missions of VP&S MSTP include: 1) Enhancing reproducibility of biomedical research
results through training in scientific rigor and transparency; 2) Promoting a training culture with highest
standards to ensure the safety, ethics, and well-being of all; 3) Imparting appreciation and ability to work in
diverse teams and cultivate inclusivity; and 4) Nurturing superb skills to communicate scientific findings to a
wide range of audiences. Critical enhancements to the VP&S MSTP include abundant career mentoring to
promote successful transition into dual-degree careers; training in rigorous research design, as well as
quantitative, computational and statistical methods; and nurturing of ethics, responsibility, diversity, and
inclusivity in biomedical research and clinical practice. The trainee cohort is superb and increasingly diverse.
More than 130 outstanding investigators act as thesis mentors. Program leadership has decades of graduate
and medical education experience. The duration of trainee appointments would be for the first 2 years of PhD
research, and the projected number of trainees across all cohorts would be 116 students. Measurable
objectives that VP&S MSTP intends to achieve are: 1) Maintaining or improving high levels of dual-degree
attainment (98%) and rapid time to completion (7.7 years); 2) Increasing the frequency of rigorous, impactful,
first-authored papers from 93% up to 100%; 3) Bettering the 5-yr average of underrepresented racial and
ethnic minority trainees (23%) to a steady 30%; and 4) Inspiring post-grad training that will increase long-term
alumni retention in research careers (70%) up to 80%. VP&S MSTP graduates genuinely learn how to discover
new knowledge, translate discoveries to the clinic, and then guide others through this critical mission.

Public health relevance
PROJECT NARRATIVE The goal of the Medical Scientist Training Program at Columbia University's Vagelos College of Physicians and Surgeons is to provide outstanding training in rigorous, responsible biomedical research that will benefit human health, integrated with exceptional training in modern principles and ethical practice of medicine and patient care. A longstanding challenge for modern medical practice is rapidly applying cutting-edge scientific discoveries into better diagnosis and treatments for patients. Training contemporary clinician-scientists in a highly integrated MD-PhD dual-degree program that places great emphasis on diversifying the trainee pool and retaining program graduates into long-term research careers would, therefore, be of substantial benefit to the health and well-being of the nation's populations.